Developing broad-based treatments for respiratory viruses by targeting host cell TTSPs

Project Summary / Abstract
We propose to develop a novel therapeutic for respiratory viruses, including all current and predicted SARS-
CoV-2 variants, other coronaviruses, influenza, and paramyxo/pneumoviruses—using a peptidomimetic small
molecule approach targeting TMPRSS2 and other trypsin-like proteases (TTSP) that are essential for virus entry.
We expect our therapeutic platform to be applicable and effective for prophylactic use, and so we will target virus
transmission studies in vivo. As our system is based on simple-to-synthesize peptides, which act outside of the
cell, is it expected to be cost–effective, and our approach is specifically designed to cover a range of distinct
viruses. However, it is important to note that our platform is highly flexible, and be applicable in the face of a
novel viruses that may emerge, without significance anti-viral resistance (as it is host-targeted).

Public health relevance
Project Narrative We propose to develop a novel, cost-effective, and highly flexible therapeutic platform to treat a range of respiratory viruses. We will use an innovative design approach, based on targeting host cell proteases, and test both the therapeutic and prophylactic response and protective response in a mouse and ferret models. Due to the conserved nature of the target, we anticipate that our approach will be applicable to and effective across a wide range of existing and emerging viruses.